WESTAT:1109753 [21-033294]

This Call Order provides support for Quality Control and Quality Improvement (QC/QI) activities in the Surveillance Research Program related to the development of new and customization of the existing tools and software for cancer surveillance data acquisition and linkage including Whole Slide Imaging (WSI) 00 caMicroscope and Annotation Tool.